FY24/FY25 FFRDC LEASES OPERATIONAL TASK ORDER

FFRDC Leases Operational Task Order Lease requirements at the Federally Funded Research and Development Center (FFRDC) at the Frederick National Laboratory for Cancer Research (FNLCR) for the National Cancer Institute’s( NCI) Divisions, Offices and Centers (DOCs) and National Institute of Allergy and Infectious Diseases
(NIAID).

NCI Lease Facilities:

8560 Progress Drive, Frederick, MD 21702
4600 Wedgewood Blvd., Suites H, K, N and M, Frederick, MD 21703
Building 425, Ft. Detrick, Frederick, MD 21702
Building 363, Ft. Detrick, Frederick, MD 21702
2099 Gaither Rd., Rockville, MD

NIAID Lease Facilities:

5705 Industry Lane, Frederick, MD 21704
7114 Geoffrey Way, Frederick, MD 21704
7116 Geoffrey Way, Frederick, MD 21704
Building 310, Ft. Detrick, Frederick, MD 21702
Building 315, Ft. Detrick, Frederick, MD 21702